RACIAL DISPARITY IN THE ENERGY DEPENDENCY OF TRIPLE NEGATIVE BREAST CANCER

Abstract: Breast cancer (BC) statistics over the years have repeatedly shown that while BC incidence is
higher in Caucasian (CA) women, death due to BC is higher in African American (AA) women. Importantly, AA
patients are more likely to be diagnosed of BC at a younger age and have a higher probability of developing
aggressive triple negative (TN) BC. AA TNBC is also diagnosed with a more advanced stage of the disease
compared to CA women. This project plans to address the differential mitochondrial reprogramming between
AA and CA TNBC patients. Considering our previous publication and preliminary data, here we use modulation
in the activation of Src oncopathway as a major readout of metabolic reprogramming. We have previously
showed that TNBC cells have high energy dependency to fatty acid β-oxidation (FAO) and FAO is an important
determinant of Src activation by autophosphorylation at its Y419 site. However, our recent analyses suggest
that this dependency is mostly restricted to CA TNBC. AA TNBC cells are not responding to FAO inhibitors as
observed with most of the CA TNBC, and FAO inhibitors do not decrease Src autophosphorylation in AA
TNBC. Further analysis suggest that, even though Src depends on Krebs cycle (TCA) activity in both AA and
CA TNBC cells, the source of acetyl-CoA for TCA is significantly different between these two groups. Thus, this
project is planning to address the disparity in energy dependency between AA and CA TNBC tumors. Our
preliminary data also suggest that increased Myc, pyruvate carboxylase (PC) and argininosuccinate synthase
1 (ASS1) activities in AA TNBC are critical in their enhanced arginine pathway. We have also proposed a
translational aim to understand the role of TCA inhibitors in the therapeutic response of AA TNBC to Src
inhibitors. Thus, this project will provide critical information regarding the energy dependency and onco-
pathway activation in AA TNBC. The project involves experiments utilizing several AA and CA TNBC cell lines,
patient-derived xenografts (PDX) models as well as deidentified BC tissues obtained from AA and CA TNBC
patients. This project also involves genomic, proteomic, metabolomic, bioinformatic and clinical approaches
including in vivo studies in animal models. Overall, this study will provide an important scientific mechanism
behind the racial disparity of energy dependency and regulation of onco-pathways in AA TNBC patients. The
outcome can support in the development of race-specific combination therapies for the management of
aggressive TNBC.

Public health relevance
Triple negative breast cancer (TNBC) currently shows racial disparity between African American (AA) and Caucasian (CA) population. We discovered critical differences in the energy dependency of AA and CA TNBC. Using multiple OMICS and translational approaches, this project is aim to understand the difference in the energy dependency of AA TNBC compared to CA TNBC and its significance in the regulation of cancer pathways.